HTORR/ NIMH ASD and Control Brain Recovery Project

Program Director/Principal Investigator (Last, First, Middle): Bell, Thomas, J.
PROJECT TITLE: HTORR/ NIMH ASD and Control Brain Recovery Project
PROJECT SUMMARY (PY7):
The Human Tissue and Organ Research Resource (HTORR) is a program of the National Disease
Research Interchange (NDRI) and is an essential resource that uses systems customized to meet
individual researcher requests to recover and distribute a broad range of high quality normal and
diseased human tissues recovered from a diverse donor pool to facilitate their research needs. In 2015,
NDRI established the Autism Spectrum Disease (ASD) HTORR program to recover ASD and control
brains to support the advancement of ASD research. This program has been continuously funded for five
program years by the National Institute for Mental Health (NIMH) via an administrative supplement (grant
number 5U42OD011158) to the parent HTORR. The supplemental grant enabled the establishment of a
network of tissue source sites (TSS) for the purpose of screening acute death referrals for eligible ASD
and control donors. In years 1 through 5 of the program, NDRI developed and maintained a TSS network
of 14 tissue source sites that serve a population of approximately 60 million and screen approximately
500,000 acute death referrals for eligible donor candidates for this program. The ASD HTORR program
has been successful with the development and implementation of a standard practice to identify both
ASD and control brain donors for this important research resource. In PY7, the program predicts that a
total of 15 brain recoveries will occur. In addition for PY7, HTORR is proposing the following key
objectives to maintain and enhance the efforts of the program HTORR will: 1) provide oversight and
project management for the ASD HTORR brain recovery network via regular outreach, conference calls
and site-visits, 2) maintain the screening, authorization, recovery, packaging and shipping requirements
for the ASD HTORR brain recovery network, 3) uphold all IRB requirements for the project through
NDRI’s IRB protocol with the University of Pennsylvania, including the ASD HTORR project-specific
donor authorization and donor screening worksheet, 4) conduct brain recovery retraining events, as
needed, to preserve the technical expertise of the ASD HTORR brain recovery network, 5) coordinate
donor screening, brain recovery, and packaging with the ASD HTORR brain recovery network and
shipping to the National Institute of Health NeuroBioBank at the University of Maryland (NIH NBB-Maryland),
6) provide eight ASD and seven control brains and matched temporal muscle samples from donors within
the age range of 2 to 30 years to the NIH NBB-Maryland, and 7) promote the ASD HTORR program and
NIH NBB-Maryland at two or more national meetings.
RELEVANCE:
The proposed continuation of the Autism Spectrum Disease Human Tissue and Organ Research
Resource (ASD HTORR) program into PY7 will help to meet the unmet demand for brains from post -
mortem donors with and without a history of ASD. The establishment of the ASD HTORR program
maximizes the identification of eligible donors and recovery of the appropriate biospecimens needed to support
the advancement of basic research evaluating the etiology of ASD, as well as translational research assessing
effective diagnostics, therapies, and cures. The enhanced capabilities of the ASD HTORR brain recovery
network also provide for future opportunities to recover brains from donors with other neurological diseases
and disorders as well.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Bell, Thomas, J. PROJECT NARRATIVE: The research demand for human biospecimens continues to grow and the NIH-funded Human Tissues and Organs for Research Resource (HTORR) provides a unique service to biomedical investigators whose research requires access to normal and diseased biospecimens. Through continued generous support of the National Institute of Mental Health (NIMH), the capacity and capability of HTORR has been expanded to include the identification of eligible donors with and without a history of Autism Spectrum Disorder (ASD) and recovery of the appropriate biospecimens needed to support the advancement of ASD research. This established program has been continuously funded for six program years and is called the ASD HTORR Program. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page Continuation Format Page